Metabolic Control of Cardiac Pacemaking

Project Summary
The cardiac cycle starts with the production of an action potential (AP) by pacemaking cells in the sino-atrial
node (SAN), initiating the propagation of electrical signals that trigger atrial and ventricular contraction. We have
discovered that the organization of the SAN microvasculature varies regionally, a variability that serves to match
blood supply to local myocyte excitability. These observations have led us to propose a new model for the
metabolic control of excitability and cardiac pacemaking activity. In our model, the highly vascularized superior
SAN is populated by myocytes capable of undergoing periodic voltage oscillations, some of which do not reach
AP threshold. Despite these failures, the many oscillations that do reach threshold can still enable superior SAN
myocytes to exhibit a high intrinsic AP firing rate, even if their periodicity is not optimal. By contrast, inferior SAN
myocytes are sparsely vascularized and have a low AP firing rate. Importantly, inferior SAN cells produce
stochastic subthreshold electrical signals. We propose that, when these subthreshold events coincide with an
electrical signal from the more periodic voltage oscillator in the superior SAN, the subthreshold signal events
integrate and, at their peaks, increase the probability of the superior SAN crossing the threshold and generating
an AP. Accordingly, inferior SAN cells that produce these random electrical signals act through a stochastic
resonance mechanism to increase the strength and periodicity of superior SAN activation. A key feature of our
proposed conceptual model is that inferior SAN myocytes do not fire APs at high frequencies for prolonged
periods of time because they do not generate ATP at the rate necessary to sustain a high level of electrical
activity. Consistent with this, we discovered that, contrary to the prevailing view, APs induce rapid fluctuations in
ATP levels in SAN myocytes, indicating that electrical activity has an impact on the energetic reserve of
myocytes. Thus, a combination of regional variations in vascular supply and ATP dynamics help deterimine
superior and inferior SAN excitability. We will test the hypothesis that changes in vascular supply to the node
impact myocyte ATP dynamics, excitability and, hence, pacemaking activity during the development of heart
failure. A central premise of this project is that vascular supply, pacemaking activity, and ATP dynamics in SAN
myocytes are inextricably intertwined. The project will test the physiological and pathological implications of our
conceptual model with three specific aims. Specific aim 1 tests the hypothesis that stochastic resonance
increases the periodicity of SAN myocytes. Specific aim 2 tests the hypothesis that ATP consumption fluctuates
in SAN myocytes in a beat-to-beat fashion and varies regionally. Specific aim 3 tests the hypothesis that
changes in vascular supply to the SAN, as well as myocyte ATP dynamics and stochastic resonance, contribute
to alterations in pacemaking activity during the development of heart failure. The proposed studies offer an
alternative to the predominant entrainment pacemaking paradigm and have the potential to radically transform
our understanding of how the excitability of SAN myocytes is regulated in health and disease.

Public health relevance
Project Narrative Recent data from our team suggests that normal sinus rhythm emerges from a highly heterogenous electrical network along the sino-atrial node set by the intrinsic properties of the cells in specific regions and regional variation in vascular supply. The experimental and computational work proposed in this application will unveil the mechanisms underlying cardiac pacemaking and may lead to the development of rational strategies for the treatment of rhythm disturbances during heart failure.